Neutrophils and polytrauma - from recruitment to phenotypic and functional reprogramming

Abstract
The zebrafish animal model provides a unique opportunity to visualize, track and deconvolute the molecular
mechanism involved in the neutrophil response in polytrauma at a whole-animal context. The optical
transparency and ease of genetic and pharmacological manipulation of this small vertebrate system has become
a powerful tool to study neutrophils and injury, with innumerous key findings in the last decade. Herein we
propose to evaluate 1) the regulatory mechanisms that coordinate neutrophil recruitment to concurrent traumatic
injuries, 2) how neutrophils are reprogrammed at sites of traumatic injury to generate specific neutrophil subsets
that reverse migrate and disseminate inflammation in trauma, and 3) how chronic inflammation impacts such
processes. We will combine whole-animal non-invasive live imaging approach with genetic manipulation and
protein, lipid, transcript, and epigenetic profiling of neutrophils. Our research will allow us to gain a deeper
understanding of the neutrophil mechanisms involved in polytrauma inflammatory response in healthy and
metainflammation settings. Our lab has over 120 lines of zebrafish transgenic and mutant lines that allow us to
visualize and genetically manipulate neutrophils. A recent detected fruit fly infestation is creating improper
conditions that are particularly concerning for our line of work, jeopardizing our research program supported by
the parent grant. Moreover, we are also encountering additional space issues that will be limiting our research
soon as we expand our program (currently at 95% capacity). Our research program has a unique line of work
that aligned with our models, tools and skills will contribute with significant knowledge to the field of polytraumatic
injury. This knowledge will enable us to manipulate neutrophil response as a means by which to improve patient
outcomes following trauma, particularly in high-risk groups.

Public health relevance
Project Narrative My group investigates mechanisms involved in neutrophil phenotypic and functional modulation in polytraumatic injury at a whole animal scale, using the zebrafish animal model. Neutrophils play a crucial pathological role in posttraumatic inflammatory response. Importantly, dysregulation of neutrophil responses and function due to pre-existent metabolic syndrome and associated metainflammation, contribute to increased susceptibility to develop posttraumatic complications in high- risk groups. We use diet-induced metabolic syndrome zebrafish models to visualize and study neutrophil migration, behavior patterns and tissue reprograming upon concurrent trauma in diverse tissues and organs, we hope this strategy will help to develop neutrophil targeted therapeutic strategies as a means by which to improve patient outcomes following trauma, particularly in high-risk groups.